Body composition, physical activity, and cognitive function in Down syndrome

People with Down syndrome (DS) have approximately a 90% lifetime risk for developing Alzheimer’s disease
(AD). Most adults with DS experience AD-associated reductions in cognitive function which result in impairments
in capacity to perform activities of daily living. In populations without DS, mid-life obesity and low levels of
physical activity have been identified as modifiable risk factors for the development of AD and cognitive decline.
The prevalence of obesity and low levels of moderate-to-vigorous physical activity (MVPA) are higher in adults
with DS compared with their typically developed peers. However, information regarding the association between
obesity, MVPA, and cognitive function in adults with DS is extremely limited. To date, cross-sectional studies in
adults with DS have found that high levels of MVPA are associated with better outcomes for several markers of
cognitive function, including executive function, episodic memory, and overall dementia symptomology. Results
from cross-sectional evaluations of the association between obesity, defined as body mass index (BMI ≥ 30
kg/m2), and cognitive function in persons with DS have been inconsistent. Previous research suggests that other
measures of body composition, such as visceral fat and body fat percent fat might have stronger associations
with negative health outcomes for adults with DS than BMI; however, no study has investigated the association
between body composition and cognitive function in DS. Additionally, while MVPA has demonstrated potential to
reduce risk for co-morbidities such as cardiovascular disease, type 2 diabetes, and overall mortality risk even in
the presence of obesity in adults with and without intellectual disability, the potential joint association of obesity
and MVPA and cognitive function in adults with DS has yet to be investigated. To examine the role of body
composition and physical activity on cognitive function in adults with DS, we will recruit ~70 new adult participants
with DS who enroll either of our two ongoing NIH projects investigating the development of AD in adults with DS,
i.e., The Brain Outcomes with Lifestyle Change in Down Syndrome (BOLD) clinical trial (R33 AG078967) and
the Alzheimer’s Biomarker Consortium-Down syndrome (ABC-DS, U19AG068054). These projects recruit
participants across the spectrum of obesity and MVPA and include assessments of cognitive function (Down
Syndrome Mental Status Exam, modified Cued Recall, Stoops Cats and Dogs) and MVPA (7-day accelerometer)
collected using standardized protocols. For this project we will add a baseline assessment of body composition
(visceral fat, body fat percent, lean mass) using dual energy x-ray absorptiometry (DXA). The aims of this project
are to evaluate: 1) The association between body composition (visceral fat, body fat percent, and lean mass)
and cognitive function and, 2) The joint association of MVPA and obesity (visceral fat and body fat percent) on
cognitive function. Completion of this project will provide valuable experience that will be useful for achieving my
career goals of developing an independent program of research on healthy aging in DS and will provide data to
inform the development of interventions for preventing or delaying AD in DS.

Public health relevance
Project Narrative People with Down syndrome (DS) are disproportionally affected by Alzheimer’s disease (AD) and AD related cognitive decline which impacts overall function and quality of life. Modifiable lifestyle factors including obesity and physical inactivity have been shown to impact cognitive function, however limited data describing the association between obesity, physical activity, and cognitive function in adults with DS is currently available. The aims of this project are to assess the association between obesity and physical activity and the potential joint association of these two factors on cognitive function in adults with DS and results of this study will inform the development of interventions for preventing or delaying AD in DS.